Epigenetic regulation of astrocyte-specific NLRP6 inflammasome and PANoptosis in HIV Tat and methamphetamine-mediated neuroinflammation

Project Summary:
According to the Centers for Disease Control and Prevention, HIV infection and drug abuse are intertwined
epidemics that limit adherence to combination antiretroviral therapy (cART) and contribute to the worsening of
HIV-associated neurocognitive disorders referred to as "NeuroHIV." Despite the ability of cART to significantly
decrease viremia, the brain remains a reservoir of low-level HIV replication with the accumulation and
persistence of cytotoxic viral proteins, including the HIV Transactivator of transcription (Tat). Methamphetamine
is a highly addictive synthetic stimulant commonly abused by HIV-infected people worldwide. It is generally
established that HIV/HIV proteins and methamphetamine activate inflammasomes in central nervous system
cells, particularly microglia. However, there is a knowledge gap in our understanding of how HIV/HIV proteins
and methamphetamine contribute to activating astrocyte-specific inflammasomes – NLRP6, leading to
neuroinflammation, which is the focus of this study. The long-term goal is to identify the molecular mechanism(s)
involved in HIV and methamphetamine-mediated astrocyte activation, which can set the stage for developing
novel therapeutic targets to alleviate neuroinflammation associated with NeuroHIV. This proposal uses in vitro,
ex vivo, and in vivo approaches to identify the molecular mechanism(s) involved in HIV Tat and
methamphetamine-mediated astrocyte-specific NLRP6 inflammasome and its role in PANoptosis-mediated
neuroinflammation. The central hypothesis is that HIV Tat-mediated astrocyte activation and neuroinflammation
in NeuroHIV involve ZBP1/NLRP6-mediated PANoptosis. The hypothesis will be tested with two specific aims,
and the outcome of this study will set the stage for developing novel therapeutics to dampen HIV and drug abuse-
mediated neuroinflammation in NeuroHIV. Overall, this R01 application aims to determine how exposure to HIV
Tat and methamphetamine induces the astrocyte-specific inflammasome, NLRP6, and its role in PANoptosis-
mediated neuroinflammation using in vitro, ex vivo, and in vivo approaches.

Public health relevance
Project Narrative: This R01 application aims to determine how exposure to HIV Tat and methamphetamine induce the astrocyte- specific inflammasome, NLRP6, and its role in PANoptosis-mediated neuroinflammation in NeuroHIV. Using in vitro, ex vivo, and in vivo approaches, this proposal will identify the novel molecular mechanism(s) involved in HIV Tat and methamphetamine in the context of activation of ZBP1/NLRP6-mediated PANoptosis and neuroinflammation. The goal is to identify novel therapeutic targets to alleviate neuroinflammation associated with NeuroHIV, and the outcome of this study will set the stage for developing novel therapeutics.